REPOSITORY SERVICES FOR FAZST SPECIMENS

The current FAZST study attempts to evaluate the effect of folic acid and zinc supplementation on semen quality and fertility treatment outcomes (fertilization rates, embryo quality, implantation and clinical pregnancy rates) among couples seeking fertility treatments. We expect folic acid and zinc to affect positive change in all of these processes with increases in embryo quality and clinical pregnancy rates through improvements in semen parameters, particular DNA integrity.